Fc receptor targeted therapy for immune hemolytic anemia

[unreadable] DESCRIPTION (provided by applicant): Autoimmune hemolytic anemia (AIHA) is caused by the destruction of autoantibody-coated RBCs by phagocytes. Many studies have shown that the FcγRs expressed on phagocytes play a vital role in binding and phagocytosis of antibody-coated RBCs. The current therapies used to treat AIHA, such as steroids, have been shown to act by non-specifically suppressing the function of FcγRs or phagocytes and result in many unwanted side effects. This warrants a need to develop targeted therapies based on known immune mechanisms that cause AIHA. Recent studies strongly suggest that blocking FcγR- mediated phagocytosis of antibody-coated RBCs may be a viable approach for treating AIHA. Although blocking receptor functions using decoy receptor-based therapies have been proven clinically successful, the presence of high levels of circulating IgG pose a unique challenge to the use of recombinant FcγRs as therapeutic molecule. The circulating IgG will immediately neutralize if high affinity FcγRs are administered whereas low affinity FcγRs are ineffective at therapeutically achievable concentrations. We have developed a novel FcγR dimer of low affinity FcγR, CD16AIg, which can bind IC with high avidity while showing no binding to monomeric IgG. Further, our preliminary studies show that the CD16AIg dimer can block the phagocytosis of antibody-coated erythrocytes by mouse macrophages in vitro and block neutrophil extravasations and inflammation induced by ICs in vivo. In this grant application we propose to explore the possibility of using FcγR dimers as a therapeutic modality to block the clearance of antibody-coated RBCs by phagocytes in AIHA. We hypothesize that FcγRIg dimers can bind to antibody-coated RBC and competitively block phagocytosis by FcγR-bearing phagocytic cells in vivo and will restore RBC counts to the normal level. The specific aims are: 1) Determine whether competitive blocking of macrophage binding to antibody-coated RBCs by recombinant FcγRIg dimers could prevent clearance of antibody-coated erythrocytes from circulation. 2) Determine whether competitive blocking of macrophage binding to antibody-coated RBCs using recombinant FcγRIg dimers prevent experimental AIHA induced by autoantibodies of different isotypes. 3) Determine whether administration of recombinant low affinity FcγRs dimers can delay or cure spontaneous AIHA in young and old NZB mice. The results obtained from the proposed studies will demonstrate whether competitively blocking antibody-coated RBCs to phagocytes by using decoy FcγRs dimers will attenuate immune hemolytic anemia induced by IgG antibodies. These studies will also form a solid foundation for the development of novel decoy FcγR-based therapies for treatment of AIHA and other antibody-mediated autoimmune disorders in humans. [unreadable] [unreadable] [unreadable]